THE PEDIATRIC AUDIOLOGY TRANSLATIONAL RESEARCH (PAT) CONFERENCE

PROJECT SUMMARY/ABSTRACT
Hearing loss affects 12.5% of children in the United States, approximately 50% of whom have additional
disabilities. The potential for significant and lasting consequences resulting from pediatric hearing loss can be
mediated by early intervention and evidence-based interventions supporting development. Despite the growing
impetus for evidence-based practices and the establishment of practice guidelines based on scientific evidence,
delays between scientific discovery and clinical uptake are a serious barrier to improving the health burden of
childhood hearing loss. To translate research evidence into clinical practice, dissemination of research findings
must move beyond the traditional routes of peer-reviewed scientific journals which may not reach patient, clinical,
and community stakeholders in a timely manner or in ways that lead to sustainable implementation of evidence-
based practices in real-world settings. The Pediatric Audiology Translational Research (PAT) Conference
develops new insights and applies different solutions to improving the health burden of childhood hearing loss
as it is 1) the only non-industry sponsored conference specifically dedicated to promoting translational research
in pediatric audiology, 2) hosted in an environment unique in its longstanding tradition of collaboration between
trainees, clinical staff, and research scientists, and 3) deliberate in consideration of diversity in terms of race,
ethnicity, ability, and background during all conference phases. AIM 1 brings together aspiring, new, and
established clinical audiologists, research audiologists, and research scientists offering sessions developed by
leading translational researchers and master clinicians and broad advertising through professional networks,
scientific organizations, and university systems including past and current participants in the Innovative
Mentoring and Professional Advancement through Cultural Training (IMPACT) program and the Summer
Undergraduate Research or Internship Experience in Acoustics (SUREIA) program, as well as members of the
Black, Indigenous, and People of Color researchers and clinicians in Communication Sciences and Disorders
(BIPOC-CSD). AIM 2 promotes and supports inclusivity and representation in pediatric audiologic service
providers in educational, clinical, and research settings with input from Steering and Advisory Committee
members representing diverse perspectives in terms of gender, background, ability, career stage, and racial and
ethnic category, as well as student travel awards based on meritorious research and need, recognizing that
privileges to participate in high-level mentored research are unavailable to all students. AIM 3 promotes bench-
to-bedside expedience in pediatric audiology translational research findings and discovers new areas of need
within the pediatric audiology translational research landscape offering sessions that facilitate robust cross-
discipline discourse in domains supporting improved health outcomes for children with hearing loss and provision
of speaker summaries of translational findings to highlight applications to improvements in clinical care or further
scientific innovation as part of each session.

Public health relevance
PROJECT NARRATIVE Hearing loss affects 12.5% of children in the United States, approximately 50% of whom have additional disabilities. The consequences of hearing loss can be lessened by interventions backed by scientific evidence, but delays between scientific discovery and clinical uptake are a barrier to improving the health burden of childhood hearing loss. The Pediatric Audiology Translational Research (PAT) Conference develops new insights and applies different solutions to this problem as it is 1) the only non-industry sponsored conference specifically dedicated to promoting translational research in pediatric audiology, 2) hosted in an environment unique in its longstanding tradition of collaboration between trainees, clinical staff, and research scientists, and 3) deliberate in consideration of diversity in terms of race, ethnicity, ability, and background during all conference phases.